Mechanisms Directing Translating Complexes to Plasma Membranes for Local Translation

PROJECT SUMMARY
This proposal outlines a training program for independent scientist with a focus on mRNA localization using
genetics and molecular biology. The research outlined in this proposal will develop a platform to evaluate local
translation, a process of whose disruption results in many neurological diseases and cancer. The phenomena
directing local translation to axon termini and the Endoplasmic Reticulum (ER) have been described. Scientists
have recently made the novel discovery that local translation also occurs at plasma membranes. For example,
in Caenorhabditis elegans, ezrin/radixin/moesin (erm-1) mRNA localizes to plasma membranes with its
encoded protein, a plasma membrane-actin cytoskeleton linker that will coordinate cell shape changes. erm-
1/ERM-1 undergoes translation-dependent localization and local translation directed by its N-terminal encoded
FERM domain. However, neither the mechanisms directing their localization nor the reasons for their local
translation are understood. The proposed research aims to use erm-1 as a model to understand how mRNA
localization to the plasma membrane arises mechanistically, functionally links to protein production, and
impacts gene expression. Based on preliminary evidence, the hypothesis is that cytoskeletal components
interact with the translating complex to direct it to the plasma membrane, similar to co-translational transport of
secretory proteins to the ER. This model will be explored from a genetics and molecular biology perspective
with 3 specific aims. The first aim will test whether erm-1/ERM-1 localization occurs through diffusion or
directed transport mechanisms and explore which cytoskeletal components are required. The second aim will
develop a live imaging tool to better resolve the kinetics of erm-1 translation. The third aim will identify the
effector proteins involved in this process. Since impaired mRNA localization in neurons and other cell types
causes disease but studying mRNA localization in disease-specific models is challenging, this project will
achieve our long-term goal of characterizing novel mRNA transport pathways that have the potential to be
generalizable in human health.

Public health relevance
PROJECT NARRATIVE This proposal uses genetics and molecular biology tools to define the mechanisms directing local translation to plasma membranes. Impaired local translation in neurons and other cell types causes disease but studying mRNA localization in those contexts can be challenging. This project will achieve our long-term goal of understanding how local translation at membranes occurs by leveraging a tractable model system.